Defining functional humoral correlates of immunity to guide vaccine design

Malaria, a mosquito-borne disease caused by Plasmodium spp., was responsible for nearly half a million deaths
in 2017, with an additional 3.2 billion people at risk of disease. While aggressive insecticide-treated bed-net
distribution, mosquito control, and anti-malarial drug distribution programs have significantly reduced mortality
associated with the disease, the disease continues to spread nearly unabated, suggesting that a vaccine against
this infection is desperately needed. Despite the slow pace of malaria vaccine design, several vaccines have
shown promise in the field demonstrating 30–50% protection in field efficacy or Phase 2 trials. Correlates
analyses have suggested that both humoral immune responses and cellular immunity may both play critical parts
in protection from infection; however, the precise mechanism by which these immune responses synergize to
drive immunity may provide the critical insights to advance the design of next-generation vaccines able to provide
higher levels of global protection. Moreover, field studies have highlighted the potentially deleterious influence
of pre-existing antibodies in endemic regions on vaccine response. Thus, under this proposal we seek to exploit
our Systems Serology antibody profiling approach, across a large array of sporozoite/early liver antigens, to
define both the correlates of immunity against malaria infection following PfSPZ immunization as well as to define
the specific mechanism(s) by which pre-existing antibodies shape the response to vaccination. Ultimately, the
results from this study will provide novel insights for the development of next generation vaccines against malaria.

Public health relevance
The proposal aims to dissect and define the correlates of immunity that track with protection from malaria infection following irradiated sporozoite vaccination as well as dissect the role of pre-existing immunity in shaping these vaccine-induced immune responses.